Role of Chaperone-Mediated Autophagy in Cellular Senescence

Abstract
Loss of proteostasis and unresolved senescence are two drivers of aging, however, little is known about their
possible interplay in aging. Although senescent cells are of transient nature, abnormal tissue accumulation of
senescent cells occurs with age and contributes to functional loss and increased vulnerability to disease in old
organisms. Research on the relation between senescence and proteostasis is still limited and lacks systematic
studies on the impact of proteostasis loss in the different steps of senescence. This proposal focuses on
chaperone-mediated autophagy (CMA), a component of the cellular proteostasis network that facilitates selective
removal of proteins. Both, senescence and CMA are part of the cellular responses to damage and malfunction
with age, but the contribution of reduced CMA activity in aging to unresolved senescence has not been explored
before. Engagement and resolution of senescence require major proteome changes to modulate translation
attenuation, energetic switches, and changes in protein secretion, all of them functions that CMA modulates in
other cellular conditions. Therefore, we propose that 1) CMA may contribute to part of the proteome remodeling
required for transient senescence and that 2) the decline in CMA with age impairs senescence clearance
and leads to persistence of unresolved senescence and its long-term detrimental effects. We aim to understand
1) if CMA activity changes upon induction of senescence, 2) if CMA modulates senescence’s kinetics of and if
so, by which mechanism(s), 3) if CMA is required for senescent cells immunoclearance and 4) if restoring CMA
activity in aged mice reduces their organ senescent cell overload. We will use novel photoswitchable reporters
to track CMA after different pro-senescence stimuli, and will genetically downregulate CMA to mimic its change
in aging. Using targeted proteomics, we will study the impact of reduced CMA on senescence-triggered
translational attenuation and in the senescence-associated secretory phenotype (SASP). We have generated
mice defective in CMA in immune cells to explore the role of CMA in immunoclearance of senescence cells.
Lastly, we will undertake both genetic and pharmacological approaches to enhance CMA in old mice and analyze
the impact on the senescence cell overload of different organs. During this training period, I will be co-mentored
by Drs. Ana Maria Cuervo, Susmita Kaushik and the collaborators in this project. This excellent mentoring team
will allow me to 1) expand my technical abilities; 2) acquire a strong background on proteostasis, biology of aging
and pharmacological interventions; 3) formulate and test scientific hypothesis; 4) improve my oral presentation
and scientific writing skills; 5) consolidate a network of collaborators in biology of aging and 6) prepare me for a
postdoctoral position as the next stage of my career in aging research.
Significance: Our studies will advance understanding of the mechanism behind unresolved senescence in aging
and, if successful, will provide proof-of-concept of the value of targeting CMA in age-related conditions related
to unresolved senescence such as tissue fibrosis, chronic inflammation, cancer, and degenerative conditions.

Public health relevance
Project Narrative We seek to understand the interplay between autophagy and senescence malfunctioning as drivers of aging to guide future autophagy therapies to resolve persistent senescence and ameliorate age-related diseases, such as fibrosis and degenerative conditions with unresolved senescence.